NCI Enterprise Vocabulary Services (EVS) and Operations Acquisition Services

The purpose of this requirement is to acquire Enterprise Vocabulary Services (EVS) for the National Cancer Institute’s (NCI) Center for Biomedical Informatics and Information Technology (CBIIT) and its support of integrated Information Technology (IT) and biomedical informatics coordination and management efforts. The objective is to acquire contractor services for EVS Operations support. This requires providing professional staff with clinical, biomedical, and informatics expertise, as well as strong biomedical terminology/ontology and information technology experience to provide a variety of semantic services. Services include: vocabularies and other semantic products analysis; modeling and design, development, documentation, operations, and new terminology development. It also requires providing user community services for the NCI Enterprise Vocabulary Services (EVS) Program. The goal is to comprehensively review, maintain, and improve EVS content resources, infrastructure/architecture, workflows, and services while ensuring uninterrupted operations.